CE25-149 - Rigorous Evaluation of Community-Delivered Short- and Long-Acting Buprenorphine to People who Experience Homelessness or Live at Permanent Supportive Housing Sites

Project Abstract
The intersection of the overdose and housing crises has prompted unprecedented
mortality among our nation’s most vulnerable residents – people who experience
homelessness (PEH). Multilevel barriers to care often obstruct this population’s access
to medications for opioid use disorder (MOUD) -- a secondary overdose prevention
strategy that halves the risk of overdose and improves other health outcomes. To
eliminate the barriers associated with traveling to healthcare facilities for MOUD
appointments and prescription refills, Public Health – Seattle and King County (PHSKC)
will pilot a new MOUD service delivery model. Starting in 2025, buprenorphine
prescriptions ordered during street medicine or telemedicine encounters at participating
encampments, shelters and permanent supportive housing (PSH) sites will be filled at
the Downtown Public Health Pharmacy and transported by a nurse-led care team, who
will disburse short-acting sublingual and administer long-acting injectable buprenorphine
directly to patients in the field.
This study will employ a Type 2 Implementation-Effectiveness Hybrid design to evaluate
this pilot program. Using quasi-experimental methods, we will evaluate the effect of
community-delivered buprenorphine on (i) the risk of overdose in a propensity score
matched patient cohort and (ii) occurrence of overdose at PSH sites, assessed via
interrupted time series. Guided by the RE-AIM Implementation Science Framework, we
will measure patient-level and systems-level implementation outcomes. This rigorous
evaluation will generate real-world evidence for a (i) community-based MOUD delivery
model and (ii) long-acting injectable buprenorphine. Findings from this evaluation will
inform how these innovations can be adapted and brought to scale both locally and in
other jurisdictions that grapple with the syndemic overdose and housing crises.

Public health relevance
Project Narrative This study will rigorously evaluate the delivery of buprenorphine (both short- and long- acting formulations) in community settings directly to Seattle residents affected by homelessness and opioid use disorder. The study will evaluate both implementation outcomes and the effect of the intervention on overdose and other clinical outcomes. The real-world evidence generated through this study will inform other jurisdictions that grapple with the syndemic overdose and housing crises.